Mechanisms of Gap Junction Regulation

Abstract:
Gap junctions are integral membrane proteins that enable the direct cytoplasmic exchange of ions and low
molecular-mass metabolites between adjacent cells. They provide a pathway for propagating and/or amplifying
the signal transduction cascades triggered by cytokines, growth factors, and other cell signaling molecules
involved in growth regulation and development. Dysfunctional intercellular communication via gap junctions has
been implicated in causing many human diseases. The objective of this project is to use a multi-disciplinary
approach to identify the key intrinsic regulatory mechanisms that are responsible for Cx43 and Cx45 function.
The central hypothesis is that unique intermolecular interactions within the divergent CT domain of connexins
affect gap junction regulation. More specifically, we hypothesize that after myocardial infarction, differential
regulation of Cx43 and Cx45 involves specific phosphorylations and protein interactions of their CT domain. The
significance of this proposal is that discovery of how interactions mediated by the CT domain can be modulated
would open the door to strategies to ameliorate pathological effects of altered connexin regulation in the failing
heart. The following Specific Aims are proposed to investigate this concept: 1) What drives Cx43 away from gap
junctions/intercalated discs in vitro and in a murine model of myocardial infarction? and 2) What promotes Cx45
gap junction/intercalated disc localization and is Cx45 expression in left ventricle hypertrophy after myocardial
infarction an arrhythmogenic substrate? Upon completion of this project, we expect to describe novel
mechanisms by which phosphorylation and protein partners regulate Cx43 and Cx45 function and strategies by
which the pathological effects of Pyk2, Src, and Cx45 upregulation in failing hearts may be lessened.

Public health relevance
Project Narrative: Mechanisms underlying the initiation and persistence of lethal cardiac rhythms are of significant clinical interest. Changes in connexin distribution, density, and/or properties are characteristic of arrhythmic heart disease; therefore, understanding what causes alterations in gap junction properties in heart disease is essential for defining the pathological substrate and devising effective therapies. The rationale for the proposed basic science research is that understanding the mechanistic basis of Cx43 and Cx45 regulation will lead to possible points of therapeutic intervention to restore proper gap junction intercellular communication that has been altered due to heart failure.